Developing a framework to individualize surgical decision-making for older adults with primary hyperparathyroidism: Administrative supplement to promote research continuity and retention

PROJECT SUMMARY/ABSTRACT
This is an Administrative Supplement for a parent Beeson K76 Career Development award that will address
the unmet need for patient-specific decision support tools for surgical interventions in older adults and provide
a platform for Dr. Carolyn Seib to become a leader in geriatric surgery. Primary hyperparathyroidism (PHPT) is
a common endocrine disorder in older adults that is associated with serious long-term morbidity, including
osteoporotic fractures, kidney stones, and chronic kidney disease (CKD). Parathyroidectomy can prevent these
morbid sequelae. However, increased surgical risk associated with advanced age and frailty, in addition to the
competing risk of death prior to achieving benefit from surgical intervention, raises the question of whether the
risks of parathyroidectomy outweigh long-term risk reduction in this group. Identifying older adults likely to
benefit from surgical interventions, such as parathyroidectomy, while preventing overuse in this vulnerable
group, is critical to improve patient-centered care. There is no standardized methodology for developing
surgical decision support for older adults that incorporates individualized risk prediction and stakeholder input
to facilitate patient-centered decision-making. Therefore, this coordinated research and training proposal aims
to: 1) compare the effects of parathyroidectomy vs. medical management on the incidence of fractures, kidney
stones, and CKD in older adults with PHPT; 2) develop and validate predictive models for the perioperative
risks of parathyroidectomy and long-term risks of fractures, kidney stones, and CKD specific to older adults
with PHPT; and 3) design and test with stakeholder feedback a PHPT decision support tool that describes the
tradeoffs of parathyroidectomy vs. non-operative management. To accomplish these aims, Dr. Seib will obtain
training in comparative effectiveness and predictive modeling, qualitative and mixed methods research, and
implementation science, which will support Dr. Seib’s transition to research independence. Upon completion of
this research, Dr. Seib will have a user-tested risk/benefit calculator that will form the basis of a decision
support tool to improve patient-centered treatment recommendations for older adults with PHPT. In addition,
this research will establish a framework for developing patient-centered decision support that can be applied to
other conditions to promote appropriate surgical management of older adults. This proposal is significant
because it directly addresses the gap in decision support tools for PHPT and other surgically managed
conditions in older adults. This project is innovative because it proposes a paradigm shift to incorporate
geriatric principles to individualize treatment decisions in older adults with PHPT to optimize clinical outcomes.
At the end of the proposed research, Dr. Seib will have the data and skills necessary to successfully pursue
R01 funding for a hybrid type 1 effectiveness-implementation trial to test this decision support tool and apply
this methodology to other conditions with surgical treatment options that affect older adults.

Public health relevance
PROJECT NARRATIVE To make informed surgical treatment decisions, older adults and the providers who care for them must weigh the long-term benefits of surgery against the short-term health risks for an individual patient. However, counseling on the tradeoffs of surgical intervention too often rely on population average risk rather than individualized estimates of risks/benefits. This research will create a decision support tool for the management of primary hyperparathyroidism in older adults and, in doing so, establish a framework for how to combine individualized risk prediction with stakeholder feedback to develop surgical decision support that will inform treatment recommendations for older adults and reduce long-term morbidity.